Cannabis use patterns and associations with cognitive impairment in older adults

PROJECT SUMMARY/ABSTRACT
Significance. Cannabis use is increasing exponentially among older US adults (≥65 years), a population that is
expected to comprise over 20% of the population in coming decades. Older adults are particularly vulnerable to
cognitive impairment associated with cannabis use, and demonstrate increasingly heterogeneous patterns of
cannabis use (including cannabis use histories and current use profiles). Consequently, this rapidly growing
population of cannabis users will become a public health concern in coming years and merit preventive and
therapeutic interventions. Extant information on cannabis use patterns and their associations with cognitive
impairment is lacking in this critically understudied population. This research proposal examines associations
between a range of cannabis use measures and cognitive impairment, particularly residual impairment (i.e.,
cognitive effects observed after acute intoxication has passed), in older adult cannabis users. Career
Development Plan. Dr. Livne’s training program will include coursework and mentorship to develop his skills
and expertise in survey design, aging and cognition-related research, and generalized linear modeling, causal
modeling and longitudinal analyses. These are necessary for achieving his career goals of becoming an
independent investigator performing impactful research on the intersection between cannabis use, cognition,
and the aging population. Mentorship. Dr. Livne’s will be supported by a highly accomplished team of mentors
who are experts in substance use epidemiology, biostatistics, aging, and cognition. Research Plan. For Aim 1,
Dr. Livne will use data from the Health and Retirement Study, a large nationally representative study of older US
adults, to examine associations between cannabis use predictors and domain-specific cognitive impairment,
including residual impairment, among adults ≥65 years. For Aim 2a, Dr. Livne will recruit a large online sample
of older adults via social media platforms, to describe cannabis use patterns (i.e., cannabis use histories, current
profiles of use) and examine the associations between such patterns. For Aim 2b, Dr. Livne will conduct a pilot
study of a subset of respondents from the online sample as well as sociodemographically comparable older
adults with no lifetime cannabis use. Using self-administered neuropsychological assessments, he will assess
the feasibility of integrating cognitive tests in online samples of older adults and provide preliminary data on
associations between detailed measures of cannabis use patterns and domain-specific residual cognitive
impairment, expanding on analyses from Aim 1. Public Health Impact. This project will illuminate patterns of
cannabis use and associated cognitive impairment among older adults, thus informing clinicians, researchers,
and policymakers of individual and public health risks in a growing yet understudied cannabis user population.
Subsequently, findings will inform the development of harm reduction strategies and the feasibility of utilizing
online research tools for cost-effective cognitive assessment of older adult substance users.

Public health relevance
Project Narrative In recent decades, the prevalence of cannabis use has significantly increased among older adults (≥65 years), a population that is particularly vulnerable to cognitive impairment associated with cannabis use. This proposed project leverages existing nationally representative data and digital epidemiology tools to identify detailed patterns of cannabis use and the associations between those patterns and residual cognitive impairment, across several domains, in older US adults. Findings from this project will inform clinicians, researchers, and policymakers about the risks of cognitive impairment in older adults with different patterns of cannabis use, and subsequently, about the development of harm reduction strategies.